Statistical methods for gene regulatory analysis and single cell genomics

PROJECT SUMMARY
This project has three major components.
Analysis of matched accessibility, expression and 3D contact data in diverse contexts
In this component we will develop statistical methods for modeling gene regulatory relations based
on the joint analysis of gene expression data (from RNA-seq), chromatin accessibility data (from
ATAC-seq or DNase-seq) and 3D interaction data (from Hi-C or HiChIP) from diverse cellular
contexts. The focus will on “matched data sets” where the different types of omics assays are
performed on the same or closely matched cellular contexts. The methodology should be
applicable to cases when some data types are missing in a substantial subset of contexts. The
methodology should also be able to incorporate a large variety of non-context dependent data.
Analysis of matched omics data in time courses
In this component we will develop an approach to the modeling of time course data that is capable
of utilizing prior information provided by a general regulatory model learned from diverse contexts.
The emphasis will be on experiments where expression, accessibility and 3D contact data are
generated at each time points to study a specific biological processes.
Joint analysis of multiple types of single cell omics data
In this component we will develop statistical methods for the joint analysis of single cell omics data
on expression, accessibility, and 3D contact. Specifically, we are interested in the situation where
multiple types of single cell omics data are generated from the same heterogeneous population of
cells. We will develop statistical methods to resolve the population into relevant subpopulations
and to infer subpopulation-specific gene regulatory relations. We will also develop methods to
handle the case when 3D contact data is from bulk sample.

Public health relevance
PROJECT NARRATIVE The goal of this research is to develop new statistical methods for the analysis of gene regulatory mechanisms based on genome-wide data on chromatin accessibility, chromatin 3D conformation and gene expression. We will consider situations when data is available in diverse cellular contexts or in time course experiments, and will develop methods for analyzing bulk data as well as single cell data. Results from this research will enable more effective analysis of the gene regulatory mechanisms relevant to development and disease.